Infants at Risk of Autism: A Longitudinal Study

DESCRIPTION (provided by applicant): This application is a competitive renewal of a longitudinal study of infants at risk for autism (R01 MH068398, 7/1/03 - 6/30/08). In the first five years of funding, a cross-site study (UC Davis and UCLA) was conducted in which 180 siblings of children with autism were compared to 90 siblings of children with typical development on a wide array of behavioral tasks measuring constructs important to the very early autism phenotype. In this competitive renewal, we request additional funds to recruit a new sample of infant siblings and to follow longitudinally the original sample as they enter school. Based on our previous findings of few differences in behavioral symptoms at 6 and 12 months of age, experimental measures used with the new sample will focus on underlying processes that may reveal differences in at-risk children prior to the onset of behavioral signs of disorder. Collaboration with UCLA will continue for both the new sample and the longitudinal follow-up of the previous sample. Specific aims are to: AIM 1: Identify reliable markers that differentiate children with autism or ASD outcomes from children with other or no developmental delays, examining both onset of symptoms and potential underlying mechanisms to see when trajectories diverge and in what domains (Study 1: newly ascertained infant sibling sample). AIM 2: In the sample of siblings of children with autism recruited in the prior award period, examine stability of autism and PDDNOS diagnoses and identify later-appearing developmental problems by assessing functioning at age 6 (Study 2: longitudinal follow up of previous infant sibling sample). PUBLIC HEALTH RELEVANCE The long-term goal of this research is to understand the earliest features of autism, leading to the design of better screening and identification tools. In study 1, infant siblings of children with autism will be enrolled in the study before their first birthday and then followed until age 3, through the window of risk for autism development, to see how early the disorder can be identified and differentiated from other types of developmental delays. In study 2, the sample of infant siblings recruited in the prior award period will be followed as they begin school (age 6) to examine the stability of autism diagnoses and identify later-appearing developmental problems.

Public health relevance
NARRATIVE DESCRIPTION The long-term goal of this research is to understand the earliest features of autism, leading to the design of better screening and identification tools. In study 1, infant siblings of children with autism will be enrolled in the study before their first birthday and then followed until age 3, through the window of risk for autism development, to see how early the disorder can be identified and differentiated from other types of developmental delays. In study 2, the sample of infant siblings recruited in the prior award period will be followed as they begin school (age 6) to examine the stability of autism diagnoses and identify later-appearing developmental problems.